SBIR Topic 412: VivoSense Cancer Health Informatics Platform, Phase I

The overarching goal of Vivonoetics, Inc. is to develop a scalable informatics platform to conduct advanced physiological monitoring and processing of data from wearable sensors. The proposed software will perform advanced analytics for early detection, continuous assessment of disease progression and treatment sideeffects, patient centric treatment plans and decentralized data capture in cancer drug trials. In this Phase I feasibility project, Vivonoetics, Inc. will engage experts in the fields of cancer research and care to conceptualize, design and build a working prototype.